Developing Informed-consent Standards through a COmmunity-driven deliberative democracy process (DISCO) for Data to Suppression (D2S)

ABSTRACT
We will use a community-based, participatory framework to create ethical guidelines for HIV information
sharing. The proposed project builds on the “Data to Suppression” (D2S) approach in the parent grant. D2S is
a capacity building initiative, of which a central component is surveillance-based, viral suppression reporting on
clients in housing and behavioral health programs. However, the D2S project was developed without input from
clients who are served by the initiative. Many people with HIV (PWH) may not be aware that their HIV
laboratory test results are being shared, with whom their data are being shared, or what regulations exist to
govern information sharing between public health departments and health service providers. Developing a
more client-centered data sharing process can foster better public trust and engagement with this type of
public health initiative. It can also serve as a model for other jurisdictions to implement similar processes. In
order to develop an ethical consent process for data sharing, it is essential to obtain community feedback on
policies governing how data may be shared and used. In this supplemental project, we will hold a two-day,
“deliberative democracy” session among 40 clients who receive Ryan White Part A (RWPA) services to identify
community values and priorities around HIV data sharing for public health interventions. We will develop
recommendations for an informed consent and data sharing protocol for the D2S initiative. During the first
session, we will convene information sessions on current New York City Department of Health and Mental
Hygiene data sharing policies and host small group deliberation sessions where clients can propose policies
for ethical data sharing. During the second session, we will vote to ratify proposals and a consent process for
data sharing. The session will be evaluated using pre- and post- study questionnaires, qualitative analysis of
small group sessions, and through ratification of finalized recommendations and policies for HIV-related
information sharing. The work in this supplement will challenge top-down approaches to health intervention
planning and strive toward a public health framework that is truly community-driven.

Public health relevance
Narrative We propose to create a client-centered data sharing and informed consent process for the use of HIV surveillance data to improve HIV care delivery. Using an innovative “deliberative democracy” framework, we will engage people with HIV in the development of this process to ensure it reflects their community values and priorities. This process will foster increased trust in the health department via facilitation of a process whereby clients can have direct influence on policies.